EMERGENCY DEPARTMENT-INITIATED BUPRENORPHINE AND VALIDATION NETWORK TRIAL (CTN-0099). DSC5 CONTRACT. 09/20/2019 - 11/12/2022. N01DA-19-2250.

EMERGENCY DEPARTMENT-INITIATED BUPRENORPHINE AND VALIDATION NETWORK TRIAL (CTN-0099).

This study is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to the national opioid public health crisis. The NIH HEAL Initiative bolsters research across NIH to improve treatment for opioid misuse and addiction.